EBNA1 Inhibitor for Treatment of EBV-positive DLBCL

PROJECT SUMMARY
The Epstein-Barr Virus (EBV) is responsible for approximately 200,000 new cancer cases each year worldwide.
Among these, EBV+ Diffuse Large B-Cell Lymphoma (DLBCL) is an emergent global cancer threat in patients
without overt immunosuppression, irrespective of age, and represents a growing unmet medical need. New
therapeutic approaches are needed to treat EBV+ DLBCL. Only one viral-encoded protein, EBNA1, is
consistently expressed in all known EBV-associated malignancies and is a validated target for inhibition of EBV-
dependent transformation and carcinogenesis.
Investigators at the Wistar Institute have developed VK-2019, a first-in-class EBNA1 inhibitor as a therapeutic
agent, selecting it from over 2500 candidate inhibitor compounds during the hit-to-lead and lead optimization
phases. VK-2019 meets or exceeds industry-accepted criteria for potency, selectivity, metabolic stability, drug
suitability, drug safety, toxicology and bioavailability. We anticipated that VK-2019 would have a favorable safety
profile because there are no human orthologs of EBNA1. Based on preclinical evidence and a first-in-human
Phase I clinical study in patients with advanced nasopharyngeal carcinoma (NPC), VK-2019 met all safety,
tolerability and pharmacokinetic endpoints with few documented adverse events (AEs) or Severe Adverse
Events (SAEs). In this early study, we observed stable disease in more than a third and a significant decrease
in EBV plasma levels, a known biomarker of NPC progression, in more than half of the patients, that correlated
with pharmacokinetic exposure. We believe that data from this Phase I study are encouraging in terms of both
on target effect and clinical benefit, and supports a follow-on proof-of-concept study in patients with EBV-positive
DLBCL.
The purpose of this grant is to fund a phase Ib clinical trial of daily oral administration of VK-2019 to (1) further
confirm the safety profile and determine any dose-limiting toxicities (DLT) in advanced EBV+ DLBCL patient
populations; (2) understand the effects of treatment on EBV-specific biomarkers, including EBV and cellular gene
expression and (3) study the effects of treatment on the tumor microenvironment and immune response.
The clinical trial infrastructure necessary for the conduct of this study is already in place at the Sidney Kimmel
Cancer Center at Thomas Jefferson University. This clinical trial will provide critical information on the safety,
tolerability, and preliminary efficacy of VK-2019 in a EBV+ DLBCL patient population. This application brings
together basic and translational investigators to understand whether EBNA1 inhibitors can be a therapeutic
option for latent EBV infection and cancer and examines the mechanism of action.

Public health relevance
PROJECT NARRATIVE New targeted anticancer agents are urgently needed for the treatment of Epstein-Barr Virus (EBV)-positive lymphomas, chief among them Diffuse Large B Cell Lymphoma (DLBCL), the most common lymphoma worldwide. VK-2019, a potent EBNA1 inhibitor, is selectively toxic to EBV-infected tumor cells, but not to EBV- negative cells in vitro and in vivo. A phase I clinical study with patients with advanced EBV-positive nasopharyngeal carcinoma demonstrated that VK-2019 exhibits a favorable pharmacokinetics and safety profile. In this Phase Ib study, we propose to confirm the safety and tolerability of the drug, obtain a preliminary signal of anti-tumor efficacy, study the effects of VK-2019 treatment on EBV and cellular gene expression and on the tumor microenvironment, in EBV-positive DLBCL patients.